Exercise as Interception Therapy in Primary High Risk Cancer

ABSTRACT
Advances in screening and adjuvant therapy have significantly improved disease outcomes in primary
(early-stage) cancer, however 30% still experience relapse despite curative treatment. Recurrent (metastatic)
disease is currently incurable. Thus, effective strategies to prevent disease recurrence in those patients at
highest risk are of major clinical importance.
Exercise therapy is a well-tolerated strategy that may also hold significant promise to control MRD in
breast, prostate, and colorectal cancer. Observational studies show that self-reported exercise is associated
with 20% to 60% reductions in the risk of relapse in primary breast, prostate, and colorectal cancer. Moreover,
these observations extend to patients with high-risk (e.g., stage 3, node positive) disease. In preclinical support
of these data, we have demonstrated exercise significantly inhibits primary tumor growth in aggressive mouse
models of breast, colorectal, and prostate cancer. Finally, we have translated the development of exercise
interventions to the clinic with numerous prospective trials demonstrating exercise training is safe, well-
tolerated, and exhibits significant pharmacodynamic (PD) activity as illustrated by favorable alterations in the
circulating availability of multiple growth factors and hormones as well as inflammatory-immune effectors
known to affect cancer cell proliferation and survival in breast, prostate, and colorectal cancer. Collectively, the
encouraging data strongly support further clinical investigation of whether exercise has adjuvant therapy
benefit in patients with primary solid tumors.
We will conduct a phase 1a/1b study of exercise in primary cancer patients at high-risk of disease
relapse. We will leverage analysis of circulating tumor DNA (ctDNA) to: (1) identify those at high-risk of relapse,
and (2) monitor therapeutic response to exercise. This grant has two specific aims: (1) Aim 1: Phase 1a Dose-
Finding and (2) Aim 2: Phase 1b Dose Expansion.

Public health relevance
PUBLIC HEALTH STATEMENT In this grant, we will investigate, for the first time, the antitumor effects of exercise on minimally residual disease in patients with high-risk with primary breast, colorectal, or prostate cancer. As such, if successful, the findings of this study could benefit hundred of thousands of patients with or at risk of these cancers and therefore have significant public health impact.